A high-throughput, multimodal strategy to improve variant classification

PROJECT SUMMARY---------------------------------------------------------------------------------------------------------------------
The timely and accurate genetic diagnosis of Mendelian diseases enables interventions to prevent catastrophic
outcomes such as progressive heart failure and metastatic cancer. These diagnoses depend on the ability to
distinguish pathogenic variants from benign. However, the vast majority of variants that have been identified in
disease genes are currently classified as variants of uncertain significance (VUS), which are not clinically
actionable. This “VUS problem” represents a major barrier to the implementation of Genomic Medicine. This
proposal aims to address the VUS problem by employing a novel, integrative approach to prospectively assess
variant pathogenicity. This approach will leverage the enormous genotypic and phenotypic variation present in
large, DNA-linked biobanks together with the results of high-throughput, in vitro functional assays with the goal
of generating sufficient evidence to reclassify VUS as either pathogenic or benign, at scale. To capitalize on the
PI’s expertise in computational electrophysiology and Cardiovascular (CV) Medicine, the proposed research
will focus on CV disease-associated genes; however, the methods developed in this proposal will be designed
to generalize to Mendelian disease in any organ systems. The overall aim of this proposal is to accelerate the
implementation of Genomic Medicine through the prospective reclassification of disease-gene VUS. The first
aim of this proposal is to develop and validate CV gene-specific phenotype risk scores (PheRS) in the large,
DNA-linked biobanks All of Us, the UK Biobank, and Vanderbilt’s BioVU, which, collectively, will have whole
genome sequences for over 1 million participants linked to phenotypic data. These PheRS will be developed to
capture a spectrum of phenotypes detectable in the biobank records with the purpose of amplifying the often-
faint phenotypic signal associated with rare pathogenic variants in population studies. The second aim of this
proposal will generate evidence to reclassify CV disease-gene VUS in the biobanks by deploying the biobank-
calibrated PheRS in conjunction with Multiplexed Assays of Variant Effects (MAVEs), high-throughput, in vitro
assays which generate functional data for nearly all possible protein-coding variants in a gene of interest. This
proposed research will be conducted at Vanderbilt University Medical Center (VUMC), under the guidance of
an exemplary mentorship team and in parallel with a thoughtful career development plan. VUMC is a world
leader in Genomic Medicine and Biomedical Informatics, and thus an ideal environment for the PI’s continued
training. The career development plan has been tailored to develop further expertise in human genetics,
biomedical informatics, and Genomic Medicine. Overall, the research, environment, mentorship, and training in
this proposal will give the PI with the necessary experience to successfully transition into an independently-
funded physician-scientist.

Public health relevance
PROJECT NARRATIVE------------------------------------------------------------------------------------------------------------- Everyone carries genetic variants, or mutations, but only some of these variants cause disease. This research aims to improve our ability to identify which genetic variants are likely to cause disease. This will enable individuals with disease-causing variants to get medical treatment to prevent severe disease and death.